Biology-aware machine learning methods for characterizing microbiome genotype and phenotype

PROJECT SUMMARY
The Mirarab laboratory designs computational methods for answering biological and biomedical questions, fo-
cusing on scalability and accuracy. These methods span several areas (e.g., microbiome proﬁling, multiple
sequence alignment, and phylogenomics), and a common thread among them is evolutionary modeling. More
recently, many of the developed methods are based on machine learning. The lab has developed scalable and
accurate methods for reconstructing evolutionary histories (i.e., phylogenies) and using these histories in down-
stream biomedical applications. Methods developed by this lab (e.g., ASTRAL, SEPP, DEPP) are at the fore-
fronts of modern genome-wide phylogenetics. While the lab has previously focused more on inferring species
histories, through an MIRA grant, it has shifted its focus to developing methods for microbiome analyses, which
pose their a unique set of challenges.
As part of the MIRA application, the Mirarab lab will focus on designing, testing, and applying improved
methods for statistical analyses of microbiome data. These methods will target two questions. (i) Proﬁling:
What organisms constitute a given sample? (ii) Association: How are samples different in their organismal
composition, and how do these differences connect to measurable characteristics of their environment? While
both questions have been subject to considerable research, many computational challenges remain, providing
an opportunity for better methods to make a signiﬁcant impact. Instead of focusing solely on new algorithms,
the lab will also work on building better reference datasets and combining data from multiple sources. Thus, the
project aims to harness the unprecedented computational power, large available datasets, and recent advances
in machine learning to improve state-of-the-art dramatically. The project will not use off-the-shelf machine
learning methods in a black-box fashion. Instead, it develops methods that incorporate biological knowledge
(e.g., of the evolutionary relationships) into machine learning methods in a principled biologically-motivated
fashion.
Within the context of the MIRA award, this supplementary request is to purchase a computing server. The
server will enable the lab to take advantage of the unprecedented level of genomic data available today to build
machine learning methods that are trained on a much more representative set than existing methods. Thus,
the extra computational power will not be just in the service of making analyses faster: it will enable using large
datasets for training that could not be otherwise used.

Public health relevance
PROJECT NARRATIVE Despite intensive efforts to develop methods for analyzing fast-growing environmentally-sequenced microbiome data, many challenges remain, and there is substantial room for improvements. We will build several methods for building better reference datasets, increasing the accuracy of proﬁling contents of microbiome samples, and ﬁnding associations between changes in the proﬁle and phenotypes of interest. Our publicly available methods will use advanced algorithms, statistics, and state-of-the-art machine learning techniques, but will adopt these techniques to incorporate a deep understanding of the evolutionary processes that shape the microbiome.